DIET/VIT E NONALCOHOLIC STEATOHEPATITIS IN HEPATITIS C

To determine if dietary manipulation and vitamin E supplementation will reduce transaminase levels in non-alcoholic statohepatitis (NASH) patients.